Regulation of the tuft-ILC2 circuit in the small intestine

Project Summary
Parasitic worms (helminths) currently infect 1-2 billion humans and are the cause of widespread morbidity.
Helminth infections of livestock result in large economic losses. Meanwhile, the incidence of allergies is
increasing globally, but particularly in regions where helminths are absent. Although seemingly unrelated,
helminths and allergens are immunologically linked as they both induce a type 2 immune response. The
activation and regulation of type 2 immunity remain incompletely understood, especially in the small intestine
(SI). We recently discovered that rare chemosensory epithelial tuft cells are required for anti-helminth immunity
in the SI. Tuft cells activate group 2 innate lymphoid cells (ILC2s), which in turn secrete canonical type 2
cytokines to coordinate hallmarks of type 2 immunity, such as eosinophilia and tissue remodeling. Specifically,
IL-13 signaling in epithelial progenitors biases their lineage commitment towards tuft cells, leading to tuft cell
hyperplasia during helminth infection and in mice colonized with Tritrichomonas protists. This tuft-ILC2 circuit is
activated when tuft cells sense succinate secreted by Tritrichomonas, but the ligand and receptor mediating
helminth sensing remain unknown. Additionally, while the cells and intercellular signals of the tuft-ILC2 circuit
are emerging, the intracellular signaling pathways that regulate the circuit remain completely unknown,
especially within the epithelium. In this proposal, we examine how POU2F3 is regulated to induce tuft cell
hyperplasia (Aim 1), test the function of KIT signaling in tuft cells (Aim 2), and characterize novel tuft cell
ligands and the intracellular signals they activate (Aim 3). In addition to helminth infection, the tuft-ILC2 circuit
has recently been implicated in enteric virus infection and ileitis induced by bacterial dysbiosis. Therefore, the
regulatory mechanisms uncovered by this project promise to identify therapeutic targets for the treatment of
numerous SI pathologies.

Public health relevance
Project Narrative Parasitic worms, allergens, and some protists all trigger a “type 2” immune response, but we do not yet fully understand the underlying mechanisms of immune sensing and regulation. More than 1 billion individuals are currently infected with worms, and the incidence of allergies is rising worldwide. By studying the role of epithelial tuft cells in type 2 immunity, we hope to discover novel targets for therapeutic intervention in helminth infection and allergy.